GGT Targeting Suppresses Mast Cell Activation by IgE and IL-33

Mast cell activation by IgE or IL-33 elicits powerful inflammatory responses contributing to
allergic disease, a significant health burden in need of novel therapies. Cholesterol-lowering
statin drugs targeting HMG Co-A reductase (HMGCR) suppress allergic inflammation in some
clinical trials, but effects are inconsistent. Our data suggest that this variability is due to statin
resistance that can be circumvented by targeting geranylgeranyl transferase (GGT) downstream
of HMGCR. Therefore, this application will test the hypothesis that GGT inhibition suppresses
mast cell functions induced by IgE and IL-33. Our preliminary data show statins and GGT
inhibitors can block mast cell function in vitro and in vivo. The proposed studies include
mechanistic investigations of how GGT blockade alters specific Ras family proteins, as well as
the effect of GGT inhibition on IL-33-mediated glycolysis. We further include studies of human
mast cells and in vivo models that will reveal fundamental insights into mast cell biology and
offer translational potential. We have two Specific Aims:
Aim 1: We will determine the effects of GGT blockade on IgE signaling, in vitro and in vivo.
Aim 2: We will determine the effects of GGT inhibition on IL-33-mediated mast cell function, in
vitro and in vivo.

Public health relevance
Mast cell activation by factors such as IgE antibodies and the cytokine IL-33 occurs early in many immune responses, and is a central factor in some pulmonary diseases. Our data show that cholesterol-lowering statin drugs are powerful suppressors of mast cell function, but that drug resistance is common. We find that statin effects are actually due to loss of geranylgeranyl transferase (GGT) function, and that GGT antagonism reliably inhibits mast cell function. This application will determine how GGT inhibition disrupts mast cell-mediated responses and how this can be accomplished in vivo